Duke University Program in Environmental Health

Environmental chemicals and stressors are major contributors to disease. Our ability to reduce harm is limited by uncertainties about exposure, poor understanding of the exposures or exposure mixtures that cause health effects and the mechanisms by which they do so, as well as by limited ability to remediate polluted sites and treat diseases. Interdisciplinary expertise is required to rigorously quantify exposure and health effects to assess and manage risk, and to develop novel tools for exposure reduction, remediation of polluted sites, and treatment of disease.
The Duke University Program in Environmental Health (UPEH) rigorously prepares students for the
complexity of research careers in environmental health by leveraging and integrating the highly complementary disciplinary strengths of Duke’s internationally-renowned Schools of Medicine, Environment, and Engineering, and Departments of Biology and Statistics. The UPEH is a critical, keystone element of Environmental Health research and training at Duke. It makes possible a larger, interdepartmental, transdisciplinary program called the Integrated Toxicology and Environmental Health Program, which was initially created in 1978 in the Duke Medical Center. By supporting predoctoral and postdoctoral training, the UPEH T32 creates a force-multiplying environment that trains many more PhD students and postdoctoral Environmental Health researchers than are supported financially by the T32. Importantly, Duke is fully invested in supporting this training program, offering very extensive support for Environmental Health training that complements the UPEH, and hosting twelve additional major environmental health-related centers and initiatives that enormously enrich the learning environment for our trainees. Finally, while the outstanding Duke UPEH faculty serve as primary advisors for trainees, the Program is further enriched by adjunct faculty and external advisors from our neighboring Research Triangle Park-based institutions such as the NIEHS, US EPA, and RTI, and our
sister triangle universities (North Carolina Central University, NC State University, and UNC Chapel Hill).
UPEH trainees receive high-quality training including: (1) development of essential research skillsets including content mastery in core disciplinary areas (Environmental Health, Toxicology, Exposure Science, Epidemiology, Environmental Engineering, etc.), quantitative methods (Biostatistics, Exposure Science Modelling, Big Data Analytics, etc.), and training in responsible conduct of research and rigorous and reproducible experimental design; (2) critical and creative thinking, and a research mindset focused on interdisciplinary problem-solving via cutting-edge, innovative research; and (3) knowledge, professional skills, and experiences required to identify and transition into environmental health careers. The UPEH fosters a supportive training environment in which all trainees can prosper, as evidenced by the success of alumni.
Modified Section B6
There are no major changes to our proposed Goals and plans. However, there are several
minor changes:
The creation of an ITEHP (Integrated Toxicology and Environmental Health Program,
the umbrella group that the UPEH T32 supports) Student Group. UPEH students
have initiated, and received approval for, the formation of a student-led committee
that aims to build on and improve culture within the department. Recommended
structure and goals of the committee include: community-building aspect in which
the committee can plan and execute events; planning two seminars per semester,
including speaker selection; “About Me” portion of meeting for students and faculty
to learn more about each others’ various backgrounds; participating in applicant
recruitment at conferences; and electing a student representative to attend UPEH
Executive Committee meetings.
Postdoc recruitment. Because moving can be a barrier, we are considering
recruiting PhD graduates from geographically proximate institutions like UNC, NC
State, NCCU, NIEHS, and EPA where the candidate would not have to move. Oak
Ridge National Lab, UT Knoxville, Wake Forest, Virginia Tech, and East Carolina will
also be included in the recruitment. We are also considering internal candidates.
The UPEH Executive Committee agreed to allow an elected student representative
from the ITEHP Student Group to attend its meetings, which are typically held one to
two times per year. The committee hopes this will provide students with
transparency in the decision-making process, insight into actionable items, and an
opportunity to learn the innerworkings of running a university PhD program.
Due to the success of the writing retreat held in June 2024, the DGS and DGSA plan
to host a writing retreat again in the spring. Students will be able to dedicate time to
writing or other PhD-related projects and individual consultations with the DGS will
be offered.
New faculty mentors: We are pleased to welcome three new faculty mentors: Jeseth
Delgado Vela, PhD; Jillian Hurst, PhD; Andrew West, PhD.

Public health relevance
Narrative Environmental chemicals and stressors are major contributors to disease; interdisciplinary expertise is required to rigorously quantify exposure and health effects to assess and manage risk, as well as to develop novel tools for reduction of exposure, remediation of polluted sites, and treatment of disease. Duke University has outstanding expertise in these areas, with top-ranked Schools of Medicine, Environment, and Engineering; Departments of Statistical Sciences, Environmental Engineering, and Biology; and the Global Health Institute. Through integration of this transdisciplinary expertise, the Duke University Program in Environmental Health will provide pre- and postdoctoral trainees with essential research skillsets, guidance in professional development, and an inclusive and supportive training environment, thus producing deeply trained but interdisciplinary environmental health leaders who will contribute throughout their careers to solving society’s urgent environmental health needs.